ShEEP Request for 3D-Bioplotter System

In this ShEEP grant, we request funds to purchase a 4th Generation 3D-Bioplotter
Manufacturer Series manufactured by EnvisionTEC, Inc. for research applications at VA Loma
Linda Healthcare System. 3D printing is based on the principle of layered manufacturing, in which
materials are overlapped layer by layer to quickly fabricate components with any complex shape
by accurately accumulating material using solid modeling according to a computer-aided design
model or computed tomography scan under computer control. The preparation of organ models,
rapid manufacturing of personalized scaffolds, and direct printing at the defect site can be
achieved by 3D printing technology based on imaging data. 3D printers are increasingly being
used for a number of pre-clinical investigations including research on personalized manufacturing
of permanent non-bioactive implants, fabricating local bioactive and biodegradable scaffolds and
directly printing cells and tissues for regeneration studies. The 3D-Bioplotter Manufacturer Series
from EnvisionTEC was designed as a tool for advanced tissue engineering and also for use in a
production environment. It is the most versatile and advanced of the 3D-Bioplotter options and is
capable of utilizing up to 5 materials in a build as well as UV curing capabilities and both heated
and cooled platform options. It has a modular head design that allows users to add new features
to existing machines. It is designed for use in a sterile environment within a biosafety cabinet.
This new instrument will be used by a number of investigators at the VA Loma Linda Healthcare
System (VALLHCS) to support research projects funded by VA merit review, NIH and DOD grants.
The 3D-Bioplotter printing head modalities available in the Manufacturer Series system will allow
3D printing of materials for applications that include bone regeneration, drug release, cell/organ
printing and soft tissue fabrication. A number of VA, DOD and NIH funded investigators at this
VA Medical Center including Drs. Mohan, Lau, Rundle, Dong, Li, Venezia and Xing will benefit
from being able to use this equipment to perform studies related to their funded grant applications.
Currently, no advanced 3D-Bioplotter system is available for research use at VALLHCS. The
requested instrument will greatly enhance experimental capabilities of our translational research
that are relevant to the pathogenesis and treatment of osteoporosis, osteoarthritis and hearing
loss, diseases that are target areas of the VA research mission.

Public health relevance
PROJECT NARRATIVE Veterans in general have a higher risk of developing osteoporosis and osteoarthritis, two major diseases of the skeleton, due to their lifestyles and health issues related to military service. Hearing loss is the most prevalent service-related injury among veterans. Traumatic brain injury is a significant health issue which affects service members and veterans. The 3D-Bioplotter Manufacturer Series from EnvisionTEC will be used to expand ongoing investigations that are relevant to osteoporosis, osteoarthritis, traumatic brain injury and hearing loss, areas of research that are veteran-centric. Since an advanced 3D Bioprinter for small animal translational research is currently not available at the VA Loma Linda Healthcare system, the availability of funds to purchase the 3D-Bioplotter Manufacturer Series from EnvisionTEC will have a significant impact on veteran-centric research funded by both VA and other federal agencies (NIH and DOD).